Lymphoid-specific high-efficiency beta-catenin protein degradation

ABSTRACT
As part of canonical WNT signaling, beta-catenin forms activating transcriptional complexes with TCF7 factors to
promote MYC-expression and proliferation in epithelial, neuronal, endothelial and mesenchymal cells. Despite its
critical role in multiple organ systems, beta-catenin is dispensable for normal lymphopoiesis. While other cell types
depend on beta-catenin to promote MYC-expression and proliferation, we discovered that B-lymphoid cells have
evolved and critically depend on a previously unrecognized mechanism for high-efficiency beta-catenin protein
degradation. beta-catenin mRNA levels in B-lymphoid cells were comparable to other cell types, however, beta-
catenin protein levels were 80- to 200-fold lower and often undetectable.
Lymphoid-specific high-efficiency beta-catenin protein degradation depends on concerted activity of the GSK3B
and CK1a kinases, NEDD8-activating enzyme NAE1, and the immunoproteasome subunits PSMB8 and PSMB9.
Inhibition or genetic haploinsufficiency of any of these components, reduced degradation efficiency, resulting in
beta-catenin accumulation and acute cell death of B-lymphoid cells. In contrast to activating beta-catenin:TCF7
complexes that promote MYC-expression in other cell types, our studies in B-cells revealed repressive beta-catenin
complexes with lymphoid Ikaros factors that induced transcriptional repression of MYC and acute cell death.
We propose three Aims to (1) elucidate the mechanistic basis of high-efficiency beta-catenin protein degradation
in B-lymphoid cells, (2) B-cell-specific composition and function of repressive beta-catenin complexes and (3) to
develop concepts for therapeutic intervention at the level of GSK3B, CK1a, NAE1 and PSMB8 to disrupt beta-
catenin protein degradation in B-cell autoimmune and lymphoproliferative conditions.

Public health relevance
NARRATIVE While beta-catenin forms transcriptional complexes to activate MYC-expression and proliferation in other cell types, our studies in B-lymphoid cells revealed repressive beta-catenin complexes to suppress MYC. Unlike other cell types, B-lymphoid cells critically depend on high-efficiency beta-catenin protein degradation, which requires concerted activity of the GSK3B and CK1a kinases, NEDD8-activating enzyme (NAE1), and immunoproteasome subunits (PSMB8). We propose three Aims to (1) elucidate the mechanistic basis of high-efficiency beta-catenin protein degradation in B-lymphoid cells, (2) B-cell-specific composition and function of repressive beta-catenin complexes and (3) to develop concepts for therapeutic intervention at the level of GSK3B, CK1a, NAE1 and PSMB8 to disrupt beta- catenin protein degradation in B-cell autoimmune and lymphoproliferative conditions.